A novel antioxidant delivery system, Pro-NP™, for protection against UV-related skin cancer

ABSTRACT This project aims to develop a skincare product to prevent ultraviolet (UV)-induced skin cancer with a novel antioxidant delivery system, Pro-NP™, for topical application alone or as an additive to commercial sunblock. Skin cancer is more common than all other cancers combined and affects millions of Americans every year. UV exposure from the sun or tanning beds causes the production of reactive oxygen species (ROS), which overwhelms the skin’s natural antioxidant defense and leads to oxidative stress, photoaging, and skin cancer. While commercial sunscreens can reduce the risk of developing skin cancer, they are poor at blocking UV-A rays responsible for most of the cutaneous ROS production. The topical application of exogenous antioxidants could potentially combat UV generated ROS; however, in their native state, many antioxidants are too unstable to absorb to the deeper layers of the skin effectively. The natural defense system of the skin against UV-induced oxidative stress includes antioxidants superoxide dismutase (SOD) and catalase (CAT), essential enzymes that neutralize the detrimental effects of ROS. Unfortunately, the catalytic activity of native SOD and CAT are short- lived and rapidly cleared, a limiting factor on current therapeutic strategies based on exogenous delivery. ProTransit has developed a proprietary antioxidant delivery system, Pro-NP™, specially formulated for the slow- sustained release of SOD and CAT, to overcome the limitation of the antioxidant’s short half-life. The development of our dermatological product capitalizes on the recent advances of nanotechnology to overcome the biological barriers of using antioxidants to counteract skin damage caused by ROS. Our preliminary studies are promising and demonstrate that Pro-NP™ is non-toxic in humans and penetrates to the deepest layers of the skin to release active SOD and CAT, reduces DNA damage after UV exposure, and prevents the degradation of essential skin protein fibers like elastin and collagen. The overall objective of this study is to optimize the formulation of plant-based SOD and CAT in Pro-NP™, determine the window of efficacy, compare the effectiveness of Pro-NP™ to commercially available sunscreens, and evaluate the potential of co-application of Pro-NP™ with commercial sunscreens. Our long-term goal is to develop novel, next-generation skincare products for topical application to prevent UV-induced skin damage and ultimately to reduce the incidence of skin cancer.

Public health relevance
NARRATIVE ProTransit is developing a novel, next generation skin care product, Pro-NP™, for the topical application of nanoformulated super antioxidants to prevent UV-induced skin cancer. Our nanoformulation can penetrate deep into the skin to counteract oxidative stress that leads to skin damage. Our overall objective is to optimize the formulation and evaluate the potential to use Pro-NP™ as an additive to commercial sunscreens.